MARC U-STAR PROGRAM AT WASHINGTON UNIVERSITY IN ST. LOUIS

Abstract: Through the parent MARC U-STAR grant and its affiliated programs and activities, we have built a
strong pathway for UR students to succeed in research and STEM classes at Washington University (WashU)
and to pursue their research interests upon college graduation in graduate school and MD-PhD programs. There
is however one key gap in our training in this pathway – sophomore year. Currently, we lack any structured,
research-based programming for UR students during the sophomore year. It is critical to fill this gap, as
sophomore year is a pivotal time in the academic career of college students: Most of them choose their academic
major at the end of the sophomore year. And, once students choose a major, almost all students retain that
major through graduation, as student retention in a declared science major exceeds 95% for both UR and
well-represented (WR) students at WashU. Despite this success, we observe that two-fold as many UR
students versus WR students migrate away from their intended STEM major during the first two years of
college. Our gap in research-focused programming for UR students then aligns with the timing of when the
vast majority of UR students leave their expected science major. The goal of this proposal is to fill this gap
in training through creation of the Next Generation Science Scholars Program – a sophomore year cohort-
and research-based program – in order to retain an ever-increasing number of UR students in intended
STEM majors and drive their success in research, college, and beyond.

Public health relevance
Project Narrative: Teams with diverse perspectives outperform those with more limited perspective. Programs that promote a diverse scientific workforce are the essential to continue the tradition of scientific excellence in the United States. This proposal seeks funding for an undergraduate research program that enables students from underrepresented backgrounds to carry out research and participate in academic and professional development events during their sophomore year. These activities will prepare students to enter and excel in PhD and MD/PhD programs nationwide, empowering the United States to remain the world-wide leaders in scientific research.